Mechanisms of enhancer dynamics and assembly in gene regulation

SUMMARY/ABSTRACT
Mechanisms of enhancer dynamics and assembly in gene regulation
Effective gene regulation is essential for the proper functioning of cells. Dynamic control of enhancer
repertoires drives stage-specific transcription during tissue development and disease progression. The overall
objective of our research program is to gain a fundamental understanding of the regulations of enhancer
dynamics in response to signaling and their effects on gene regulation, leading to innovative approaches to the
prevention and treatment of enhancer-related diseases. We propose the following two themes in our parental
NIGMS R35 grant to pursue this objective from multiple levels: from the enhancer chromatin organization, to
the coordination of enhanceosome components, and the molecular interactions that drive enhancer assembly.
Theme 1: To profile the context-specific enhancer dynamics and understand its functional
significance. Our previous studies have revealed that enhancer dynamics can be induced by 1) acute
hormone stimulations, which can build up the active enhancer machinery in just minutes at many chromatin
sites to turn on gene expression, and 2) chronic disease progression towards tamoxifen resistance, which
reprograms the ERα cistrome to evade endocrine therapies in breast cancer. With these two established
model systems (acute and chronic signaling), we will 1) capture the dynamic enhancer chromatin organization
with multi-omics analyses and identify candidate key transcription factors associated with enhancer
reprogramming using bioinformatic approaches; 2) define stage-specific enhanceosome components using in
vivo proximity-dependent biotin labeling BioID/TurboID technologies; and 3) introduce a series of perturbations
to understand how disruption of enhancer dynamics affects transcriptional activation and cell state.
Theme 2: To decipher inter- and intra-molecular interactions of enhancer components and their
contributions to enhancer assembly. We have revealed important principles of enhancer assembly,
including combinatorial interactions of multiple transcription factors on hormone-regulated enhancers, and
phase-separated condensation mediated by hormone receptor multivalent interactions. Further studies will
employ a diverse set of genetic and genomic approaches, as well as our recently established imaging-based
approaches, including the LacO arrays/LacI-fluorescence proteins system and a single-molecular tracking
(SMT) imaging system. Specifically, we plan to 1) investigate the behaviors of homotypic and heterotypic
multivalent interactions of enhanceosome components and their contributions to enhancer assembly; and 2)
dissect the intra-molecular interactions of hormone receptors in response to ligand binding and their roles in
regulating enhancer assembly and activity.
To understand the functional attributes of different enhancer components, we require support from this
supplemental grant to purchase a user-friendly cell analyzer with a high-throughput sampler for our planned
CRISPR screen experiments. This equipment is critical for my lab to complete this parental R35 project.

Public health relevance
NARRATIVE Enhancer regulatory elements play essential roles in development and cell function through gene regulation, and dysregulation of enhancers contributes to various human diseases. The objective of our parental R35 program is to investigate the regulations of enhancer dynamics and assembly in response to signaling and their functional importance. To understand the functional attributes of different enhancer components, we require support from this supplemental equipment grant to purchase a user-friendly cell analyzer with a high- throughput sampler for our planned CRISPR screen experiments.